Confocal Raman Microscope Acquisition

Project Summary: NIH RLI-S10: Acquisition of Confocal Raman Microscope System
The proposal aims to secure funding for the University of Puerto Rico at Cayey
(UPR-C), a non-PhD granting institution with a predominantly Hispanic student body, to
acquire the versatile and advanced XploRA PLUS Raman Microscope (XP RM). This
instrument will support and advance research activities in chemistry, biology, and natural
science at UPR-C. The XP RM system offers a range of advanced features, including
XYZ sample positioning, fast mapping, microscope visualization options, and
macroscopic observations in the UV, visible, and near-infrared regions, enabling
comprehensive sample characterization. It will directly impact on research and education,
benefiting both primary and minority users at UPR-C and other participating institutions.
The proposal outlines two educational activities and five research projects that will
utilize the XP RM system. The Physics for Bioscience course will equip students
interested in bioscience, medicine, and pharmaceuticals with the necessary knowledge,
utilizing the XP RM for pharmaceutical detection. In the Experimental Methods of Physics
laboratory, students will incorporate the XP RM to design and characterize polymeric
scaffolds for biomedical applications. The five research projects, led by two early-career
faculty, a postdoctoral fellow, and two senior faculty focus on topics such as lipid
dendrimers for drug delivery, solid electrolyte performance of medical device batteries,
polymer scaffold studies, sensors for noxious gases monitoring, and biosensors for
pharmaceutical product detection.
Acquiring the XP RM system aligns with the intent of an NIH RLI-S10 grant,
providing a cutting-edge multi-user instrument that significantly enhances capability,
resolution, and throughput. It empowers scientists from various universities to work in
diverse areas of biomedical research. Moreover, the impact extends beyond scientific
advancements, as the instrument will provide research opportunities for the Hispanic
community, benefiting over a hundred members of the scientific community in Puerto Rico
annually. The XP RM will serve as the primary instrument in UPR-C’s multi-user facilities,
fostering research and serving as a training center where students can learn advanced
analytical techniques. By actively participating in biomedical research activities and
utilizing sophisticated instruments, students gain confidence and motivation to pursue
graduate studies. The proposed XP RM system incorporates a unique alignment system,
enabling users of all skill levels, including undergraduate students engaged in biomedical
research or coursework, to acquire data without extensive training or expertise. This
inclusive approach ensures broad utilization of the instrument and promotes the
development of a diverse scientific workforce.

Public health relevance
Project Narrative: The acquisition of the XploRA PLUS Raman Microscope (XP RM) at the University of Puerto Rico at Cayey (UPR-C) is highly relevant to public health as it enables advanced research in biomedical sciences, such as the characterization of polymer scaffolds for biomedical applications, studying lipid dendrimers for drug delivery, and solid electrolyte performance of medical device batteries. The instrument's impact on research and education at UPR-C is significant, empowering underrepresented students, promoting diversity, and fostering scientific engagement through projects that utilize the XP RM in courses, laboratories, and biomedical research.